Integrated Genomic and Functional Studies of Immunotherapy for Multi-Food Allergy

Food allergies (FAs) are a world-wide problem, and allergies to multiple foods are particularly problematic.
Peanuts or tree nuts cause the majority of these deaths, and a recent survey in the U.S. found that 1.4% of
the population is allergic to peanuts or tree nuts and ~30% of patients with FAs have allergies to multiple
foods. In peanut allergy (PA), landmark studies by A. Wesley Burks and colleagues have shown that
children can be desensitized to peanut via an oral immunotherapy (OIT) protocol. We have replicated these
results in adults and children, and also have carried out a pilot study showing that FA patients can be
desensitized to multiple food allergens simultaneously (i.e., multi-OIT). Moreover, we found that there were
fewer adverse events in the build-up phase of multi-OIT if patients received the anti-IgE antibody,
omalizumab, concomitantly with multi-OIT.
In an effort to improve understanding of the systemic and local (i.e., GI) immune responses that underlie
PA and therapeutic responses to OIT, we have completed a placebo-controlled, randomized, phase 2
clinical trial of OIT in 120 children and adults with PA (the POISED trial), and have applied state-of-the-art
human immune monitoring methods to analyze blood and GI tissue specimens of participants in that study.
In our current AADCRC U19 program, we are conducting a placebo-controlled, randomized, phase 2
clinical trial of OIT with or without omalizumab or the anti-IL-4Ra antibody, dupilumab, in children and
adults with multiple FAs (multi-FAs). We are assessing a broad range of cellular findings in the blood, as
well as serologic and clinical findings, in longitudinal samples from multi-FA participants in three treatment
arms: omalizumab + OIT (N=50), omalizumab & dupilumab + OIT (N=50), and dupilumab + OIT (N=10).
We will use these data to define how key immune parameters change during multi-OIT, and which are most
predictive of the nature and durability of patient responses to this therapy. Specifically, we will evaluate
whether there are blood-derived biomarkers that predict therapeutic responses to individual allergens, or to
all allergens, in multi-OIT. In addition, we will seek to identify immune monitoring parameters, including
findings derived from analyses of basophil phenotype and function that can be rapidly performed in a
clinical laboratory using small amounts of blood, that could be used to predict the clinical reactivity to
offending allergens in multi-FA subjects, to improve the safety and efficacy of OIT protocols, and/or to tailor
the OIT protocol to each individual subject.

Public health relevance
Food allergy (FA) to multiple foods is increasingly common and can cause serious illness and death in children and adults. We use innovative approaches for immune monitoring and data analysis to investigate factors responsible for FA, and to improve our ability to manipulate the immune system to safely treat people with FAs. We are also trying to develop rapid blood tests that can be used to tailor treatment for each individual patient with FA to improve treatment safety and efficacy.